Novel medical countermeasure to mitigate potentially lethal acute radiation syndrome

Project Summary/Abstract
Despite significant advances, gaps remain in developing treatments that address persistent inflammation
that ensue after acute radiation exposure. The long-term objective of the proposed project is to develop a
well-tolerable and effective first-in-class medical countermeasure (MCM) designed for mitigation and
treatment of potentially lethal acute radiation syndrome (ARS) and administered at least 24 h post-radiation
to significantly extend survival of irradiated patients and radiation casualties.
Radiation injury is accompanied by macrophage-driven uncontrolled inflammation. Ionizing radiation
increases expression of Triggering Receptor Expressed on Myeloid cells-1 (TREM-1) in macrophages. In
animals, TREM-1 has been shown to contribute to worse survival after total body irradiation (TBI). This
implicates TREM-1 as a promising emerging target to develop a novel MCM for radiation injury.
Current TREM-1 blockers are all ligand-dependent and attempt to block binding of TREM-1 to its multiple
known and unknown ligands, bearing thus high risk of drug failure in clinical efficacy testing. First clinical
TREM-1 blocker LR12 recently failed to reach significance for the primary endpoint in phase IIb sepsis trial.
To minimize the risk of failure in the clinic, we developed ligand-independent TREM-1 inhibitory peptide
sequence GF9 that can be used as a part of trifunctional peptide GA31 formulated into macrophage-
specific lipopeptide complexes (LPC) to improve its half-life and targeting. Macrophage-targeted delivery
also addresses the potential for different TREM-1-expressing cell types (e.g., neutrophils vs macrophages)
playing different roles in the pathogenesis of inflammatory diseases. TREM-1 blockade by GA31-LPC
inhibits uncontrolled inflammatory response and ameliorates the disease in animal models of sepsis, acute
respiratory distress syndrome, sulfur mustard-induced lung injury, cancer, arthritis, retinopathy, and other
inflammation-associated diseases. GA31-LPC is safe and well-tolerable by healthy and diseased animals.
The major goal of the proposed research is to test the hypothesis that therapeutic blockade of TREM-1
by using GA31-LPC will significantly extend survival of mice exposed to LD70/30 radiation dose when
administered at 24 h or later post-radiation. Specific aims of this project are to: 1) generate, characterize
and test GA31-LPC in vitro; and 2) determine the in vivo feasibility of using GA31-LPC as a therapeutic
MCM to significantly extend survival of mice exposed to LD70/30 radiation dose.
We will generate GA31-LPC, characterize its composition, size and stability, and test in vitro in cell-
based assays. We will next test GA31-LPC in mice exposed to LD70/30 radiation dose for its ability to
improve 30 day animal survival when systemically administered 24 or 48 h post-TBI. If successful, this
project will generate preliminary data supporting the development of a new mechanism-based, well-
tolerable and effective MCM for mitigation and treatment of potentially lethal ARS.

Public health relevance
Project Narrative The proposed research is anticipated to address the urgent need to provide an effective and well-tolerable therapeutic medical countermeasure for mitigation and treatment of potentially lethal acute radiation syndrome in order to treat injuries arising from radiation exposure sustained during a radiation mass casualty incident and substantially improve outcomes and reduce the mortality rate.